Administrative Core

The Administrative Core of the Autism Center of Excellence (ACE) center, Public Health and Autism Science advancing Effectual Strategies across the life course (PHASES), will provide structure and coordination of all components: three research projects and three cores. This coordination will ensure that the PHASES Center at the AJ Drexel Autism Institute (AJDAI) is more impactful than merely the sum of its parts. The Administrative Core of PHASES has four specific aims, and 13 objectives within those aims. (1) Provide ongoing scientific and logistical oversight, support, and evaluation to the PHASES center; (2) Facilitate communication and coordination among PHASES investigators; (3) Provide administrative, budgetary, and regulatory oversight and support; and (4) Facilitate two-way communication between PHASES investigators and community stakeholders. The Core will accomplish these aims via creating and maintaining a Steering Committee that will meet quarterly, composed of project and core leadership; an external advisory committee, building from the AJDAI’s success Leadership Council; strategic planning to ensure Center activities support the mission and vision of the PHASES Center; and managing all internal and external communications, reporting, and bidirectional community engagement. The Administrative Core is well poised to complete these tasks, capitalizing on the existing infrastructure in the AJDAI, where all Core personnel are employed. The Administrative Core is also well suited to ensure ongoing synergy with the Dissemination and Outreach Core and the Data Core, as well as personnel and activities across the three Projects. All members of the Administrative Core have a history of successful collaboration with each other.